SkillFlix for Dental Professionals: Video-based Microskills Training to Improve Dental Professionals' Response to Problem Behaviors of Pediatric Patients with IDD

ABSTRACT
Children with intellectual and developmental disabilities (IDD) display more physiological stress and anxiety as
well as exhibit more problem behavior during dental exams than typically developing peers. In the United States,
children with IDD are significantly more likely to need dental visits beyond preventative care and to have unmet
oral health needs; this results in a greater prevalence of dental caries and periodontitis and less access to
prophylactic dental care. Further, there is a scarcity of pediatric dental professionals, which is greater still for
professionals explicitly trained to work with individuals with IDD and facilities that can accommodate their
needs. The American Academy of Pediatric Dentistry (AAPD) has outlined several behavior management
strategies for working with children, including guidelines for the use of chemical and physical restraint. Despite
AAPD guidelines, pediatric dentists often lack knowledge of behavioral principles and may be more likely to use
restraint in the face of problem behaviors. However, interdisciplinary teams have demonstrated the utility of
behavioral interventions to decrease problem behaviors of children with IDD in dental settings. To address
potential gaps in training, the proposed project will develop a series of Microskills™ training videos (i.e., 30-180
second video models) to demonstrate behavior management strategies dental professionals can use to mitigate
problem behaviors of children with IDD. Skills to be addressed will include pre-appointment communication,
positive reinforcement, negative reinforcement (i.e., escape), and tolerance training. This Phase I project will
develop a prototype of SkillFlix for Dental Professionals: Video-based Microskills Training to Improve Dental
Professionals’ Response to Problem Behavior of Pediatric Patients with Intellectual and Developmental
Disabilities. Phase I will focus on establishing the SkillFlix platform for dental professionals and accessing the
efficacy and acceptability of the resource for training them behavioral mitigation skills in clinical settings.
Training providers to enact mitigation strategies in clinic is expected to improve outcomes at individual dental
appointments as well as improve life-long access to preventative dental care in this population. Phase I
development will: 1) use teams of interdisciplinary experts and guardians of children with IDD; 2) conduct
formative research through focus groups, interviews, and UX research; 3) develop and refine the SkillFlix
education platform; 4) develop content and complete video production for 20 Microskills videos; and 5) conduct
a pilot study to assess the resource’s effectiveness in changing dental professional trainees’ use of behavioral
management strategies, communication with patients and guardians, confidence, and knowledge in working
with children with IDD.

Public health relevance
PROJECT NARRATIVE Over 9 million children in the United States have intellectual and developmental disabilities (IDD), and this population is at a greater risk of poor oral health, secondary infections, and chronic disease issues because they face greater biological risk factors (e.g., medications, bruxism), structural barriers from too few dental professionals and clinics capable of accommodating their needs, and they are more likely to engage in severe- enough problem behavior to the extent dental professionals cannot complete routine procedures. There is a need to better train dental professionals to adequately intervene to reduce children with IDD’s problem behavior in order to reduce their stress and anxiety before their behavior intensifies, which would increase their access to primary dental care and potentially prevent lifelong oral health issues while also increasing dental professionals’ capacity to work with this population. In response to this need, the project will develop SkillFlix for Dental Professionals, an innovative video- streaming resource of short Microskill videos that allow users to enhance their skillsets at their own pace and video order, designed to develop dental professionals’ skillsets for selecting and implementing behavioral interventions that can help children with IDD cooperate during dental exams, and potentially improve the children’s long-term oral health outcomes.